Elucidating the etiology of SPAST-based Hereditary Spastic Paraplegia

PROJECT SUMMARY
Hereditary Spastic Paraplegia (HSP) is a heritable neurodegenerative disorder in which patients suffer from
progressive weakness, spasticity of lower limbs and gait deficiencies. The disease mainly manifests as adult-
onset die-back degeneration of the corticospinal tracts (CSTs). SPAST, also called SPG4, encodes spastin,
which is an enzyme that severs microtubules. By far, SPAST is the most common gene mutated in HSP. To
date, haploinsufficiency resulting from reduced functional spastin levels has been the prevalent mechanistic
explanation for HSP-SPG4. However, haploinsufficiency fails to explain why there are no developmental
abnormalities in HSP patients and why axonal degeneration is mostly confined to the CSTs. In addition, SPG4
knockout (KO) mice display only very mild motor deficits, with no reports of CST die-back. A new mouse model
in the laboratory of the PI has been designed specifically to test gain-of-function toxicity of mutant spastin proteins
as the cause of CST die-back and HSP-like motor deficits. The central hypothesis of this proposal is that the
toxic properties of mutant spastin proteins are the cause of HSP-SPG4, whereas reduced functional spastin
levels do not cause HSP but render axons more vulnerable to the disease-specific hit. Mechanistic hypotheses
will be investigated via transgenic mouse models (including a new mouse established in the PI’s laboratory, the
SPAST knockout mouse, and the mouse that is generated by crossing the two), as well as forebrain
glutamatergic neuronal cultures derived from isogenic human induced pluripotent stem cell (hiPSC)
lines. Catwalk gait analyses and CST anatomical assessments on the mice will be conducted to compare and
contrast the phenotypes resulting from toxicity of mutant spastins with those resulting from reduced functional
spastin levels. The hypothesis will be tested that crossing the two mouse lines will result in a more extreme HSP-
like phenotype than displayed by either of the parent lines. Dose dependent cytotoxicity of accumulated mutated
spastin proteins, a key prediction of a gain-of-function mechanism for the disease, will be evaluated. Decreased
microtubule acetylation observed in the afflicted axons is posited to result from higher histone deacetylase 6
(HDAC6) activity elicited by mutant spastins and is posited to be the main cause of the die-back degeneration of
CSTs. Potential mechanistic explanations for the greater HDAC6 activity will be explored. Reduced microtubule
mobility resulting from reduced microtubule severing (due to less functional spastin) is posited to be the main
cause of the greater vulnerability of the axon to the mutant spastins. Contemporary molecular biological, live-cell
imaging, anatomical and behavioral approaches will be used to test these hypotheses. Successful resolution of
these issues will lead to better prospects for treating patients with HSP-SPG4, and also provide insights into
microtubule-based mechanisms that may be common across HSPs caused by mutations of other genes.

Public health relevance
PROJECT NARRATIVE The etiology of SPAST-based hereditary spastic paraplegia (termed HSP-SPG4) remains unknown and controversial. No effective therapy is available for HSP-SPG4 patients. This proposal, supported by strong preliminary data, is aimed at elucidating the contributions of two disease mechanisms, the knowledge of which may lead to effective treatments.